Tissue Pathology and Biospecimen Shared Resource

TISSUE PATHOLOGY AND BIOSPECIMEN SHARED RESOURCE: ABSTRACT
The Tissue Pathology and Biospecimen Shared Resource (TPB SR) provides histology services and procures,
banks, and distributes human cancer and control tissue and fluid samples. The TPB SR is directed by Kar-
Ming Fung, MD, PhD (CT), a pathologist who also serves as a liaison between SCC researchers and other
pathologists. During the reporting period, the TPB SR completed a successful integration of the pre-existing
SCC biospecimen repository into the TPB SR with a newly established annotated database and an online
catalog. Other accomplishments include a new NIH/OD S10 grant and three local grants to establish
fluorescence-based whole-slide scanning with image analysis and to expand the capabilities in automated in
situ hybridization. To ensure quality and specialization, the TPB SR is organized into two arms. The tissue
pathology arm provides: 1) consultation on experimental design and assistance in histopathologic
interpretation; 2) a complete line of histology services from tissue processing, embedding, and sectioning
paraffin and frozen bocks to construction of tissue / cell block microarrays; 3) automated single or multiplex
immunohistochemistry, immunofluorescence, in situ hybridization and TUNEL using chromogen- or
fluorescence-based detection; 4) bright-field and fluorescence whole-slide scanning with image analysis; and
5) isolation of circulating tumor cells and laser capture microscopy. The biospecimen arm provides: 1)
procurement and banking services for fresh and fixed specimens with an annotated database; 2) an online
collection catalog on the institutional intranet with a dash-board type display; and 3) search and retrieval of
archival materials from the Department of Pathology. The website and data are stored in electronically and
physically separated computers to prevent breach of information. Both arms are housed in SCC-designated
space in the OUHSC’s laboratory research complex (BRC & BMSB), a convenient location for a majority (52 of
63 total) lab-based SCC members. From 2017 to 2021, usage by Cancer Biology (CB), Cancer Therapeutics
(CT), and Cancer Prevention and Control (CPC) program members was 58%, 36% and 6%, respectively.
During this period, SCC members (full and associate) accounted for 60% of total SR usage. SCC members
with peer-reviewed support accounted for more than half (52%) of total SR usage, and 87% of SCC member
usage. SCC affiliate members (i.e., non-CCSG members who conduct cancer-related work) accounted for
another 20% of total usage. Data generated by the TPB SR was used to secure 11 peer-reviewed funded
cancer research grants as well as many other grants and scientific publications. TPB SR services are offered
free-of-charge to SCC members. This waiver of fees is approved on an annual basis by the SCC director and
provides a significant value-added benefit for SCC members to foster research.